Harnessing cooperativity to achieve high-precision in vivo measurements

Summary. The ability to measure molecules and monatomic ions in the body in real-time and with high-precision
would revolutionize many aspects of both biomedical research and clinical practice. It would, for example,
provide clinicians with immediately actionable information monitoring regarding electrolyte imbalances, and the
plasma levels of drugs of dangerous narrow therapeutic windows. To this end, we are developing
Electrochemical Aptamer-Based (EAB) sensors, a demonstrably generalizable platform technology for
measuring analyte concentrations in situ in the body. Using this technique, we have already demonstrated the
real-time, seconds-resolved measurement of more than a dozen drugs, metabolites and protein biomarkers in
the veins, brains, and peripheral tissues of live rats and the subcutaneous space of human subjects for periods
of up to 24 h. Building on this, we propose here aptamer selection and aptamer-engineering approaches aimed
at improving the sensitivity of these receptors to small changes in the concentration of their target ligands. Our
first approach to this end is overcome the often-poor affinity of small-molecule-binding aptamers, thus “tuning”
of their affinities to optimally match the concentration range of clinical interest. To achieve this, we are developing
unprecedented new selection schemes, including analog-selection, an approach for obtaining initial, if
sometimes low-performance, aptamers against difficult targets, and insertion-reselection, which recursively (and
dramatically) increases the structural complexity, and thus the performance, of these initial aptamers. Our
second aim uses the excess binding energy (i.e., dissociation constants several-fold below the necessary
measurement range) afforded by these advanced selection schemes as a basis for introducing allosteric
cooperativity, a mechanism that greatly steepens binding curves. In the near term, the expected outcome of the
proposed research will be a suite of high-precision, in-vivo EAB sensors against a set of clinically important,
narrow-clinical-window drugs, metabolites, and electrolytes. The expected long-term impact of our work
however, is much broader, as our success will establish approaches by which the responsiveness of
biomolecular receptors to changing ligand concentrations can be rationally improved, a development that will
positively impact many receptor-based biotechnologies.

Public health relevance
Health relevance. The long-term goal of this project is the development of wearable technology supporting the convenient, high-frequency, clinically-relevant measurement of electrolytes, metabolites, and drugs so providing providers and patients a real-time molecular window into health and treatment status.